Administrative Core.

The purpose of the 'Administrative Core' is as follows: (1) provide overall scientific and administrative management of the Program Project; (2) schedule, organize, and run the yearly meeting of the Program Project; (3) schedule travel for PIs/postdocs/students to go from one of the two performance sites to the other in order to conduct research; (4) organize the functions of the External Advisory Committee; and (5) develop, organize, and oversee the web site of the Program Project.

Public health relevance
Our studies are aimed at determining the elements of protein structure that create specific dynamics important for catalytic mechanism. We will understand design features that either up or down regulate enzymatic activity. The goal of this research is to lay a foundation for the development and rational design of 'allosteric' effectors or active site inhibitors based on dynamics.